Molecular Mechanisms Underlying the Effects of SSBP1 Mutation on Vision

The precise molecular mechanisms underlying retinal degeneration in mitochondrial eye diseases are poorly
understood, impeding the development of effective therapies. This proposal builds on a novel mouse carrying
the most common pathogenic variant in the Single-stranded DNA binding protein 1 (SSBP1) gene, with a
phenotype closely resembling that of patients with Optic Atrophy-13 With Retinal And Foveal Abnormalities
(OPA13). The SSBP1 gene encodes a protein crucial for mitochondrial DNA (mtDNA) replication, and mutations
in this gene cause degeneration of both retinal ganglion cells (RGCs) and photoreceptors (PRs). The long-term
goals are to elucidate the molecular mechanisms that underlie mitochondrial eye diseases, specifically focusing
on RGC and PR degeneration to pave the way for developing therapeutic interventions to restore mitochondrial
function and preserve vision. The overall objectives of this application are to assess the impact of the R107Q
variant of Ssbp1 on retinal cells and mitochondrial function and to determine whether the dominantly-inherited
variant causes dominant-negative or haploinsufficiency effects. The central hypothesis is that the R107Q variant
has a dominant-negative effect on mtDNA replication, leading to mitochondrial dysfunction, disruption of cellular
metabolism, oxidative stress, and RGC and PR degeneration. SSBP1 binds to single-stranded mtDNA as a
tetramer to prevent nucleolytic attacks, but mutations may cause aberrant multimerization, triggering pathogenic
processes. Although the underlying mechanisms of dominantly-inherited missense mutations remain unclear,
preliminary studies suggest that the R107Q mutant disrupts SSBP multimerization. The central hypothesis will
be tested by pursuing 2 specific aims: 1) Assess the impact of the R107Q variant on retinal and mitochondrial
phenotypes and on the transcriptomes of individual retinal cells using our novel knock-in mouse; 2) Determine
whether the dominantly-inherited R107Q variant causes dominant-negative or haploinsufficiency effects. Under
the first aim, retinal cell phenotypes, mitochondrial characteristics and function, energy metabolism, oxidative
stress, and mitobiogenesis will be analyzed in our novel mice compared to wild-type littermates. The impact of
the R107Q variant on transcriptomes of individual retinal cells will be explored using single-cell RNA sequencing
(scRNA-seq). Under the second aim, SSBP1 will be knocked out or overexpressed specifically in the retina using
viral vectors, and SSBP1 multimerization, retinal anatomic, and functional outcomes will be assessed. This
project is innovative because of its comprehensive molecular genetic approach to identifying factors that
influence mitochondrial function, cellular metabolism, and oxidative stress. The proposed research is significant
because it is expected to provide an understanding of the impact of the Ssbp1 variant on retinal transcriptomes
at single-cell resolution and lay the groundwork for therapies targeting dominantly-inherited Ssbp1 mutations. As
OPA13 shares phenotypic similarities with other eye diseases, this knowledge could potentially benefit patients
with a wide range of eye conditions by identifying therapeutic targets.

Public health relevance
Narrative The proposed research is relevant to public health because it focuses on understanding how a missense mutation in Single-stranded DNA binding protein 1 (SSBP1), a gene crucial for mitochondrial DNA replication, causes the blinding disease Optic Atrophy-13 With Retinal And Foveal Abnormalities (OPA13) using a patient-specific mouse model. Once the underlying mechanism for the loss of vision in OPA13 is elucidated, this knowledge could be used to identify new targets for the treatment of OPA13 as well as other, similar eye diseases. Thus, this research is relevant to the part of the NIH’s mission that is concerned with reducing illness and disability.